Developmental Research Program

Project Summary/Abstract
The Developmental Research Program provides a means to respond to new opportunities, and is designed to
encourage and facilitate new research efforts. The Program takes advantage of the broad expertise of
researchers at Johns Hopkins University (JHU), University of Colorado at Boulder (UCB), and the University of
Alabama at Birmingham (UAB), bringing in researchers from different fields (i.e. radiology, immunology,
molecular biology and genetics). It provides funds for pilot projects with potential for development into full-fledged
translational research avenues, collaborations, and new methodologies for integration into other Research
Projects. The Program is an engine of innovation in our SPORE and critical to its long term success in the fight
against cervical cancer. It is absolutely necessary to keep a mature SPORE program at the cutting-edge of
cancer research and outwardly focused by providing an avenue to solicit new research ideas and for developing
innovative high-risk, but high-impact projects to stimulate cervical cancer research in the context of the SPORE.
Pilot studies provide investigators with the resources to conduct translational research consistent with the
SPORE's objectives and within its framework to test their novel ideas while leveraging our infrastructure. This
program continues to encourage participation from a broad range of investigators at JHU, UCB, and UAB by
advertising the opportunity widely and providing support for pilot projects with the potential to develop into more
fully-developed translational projects within the SPORE or new R01-type projects that will advance our
understanding of cervical cancer biology. It also encourages and facilitates the development of new research
directions, as well as new methodologies, and collaborations that will propel our existing projects forward. To
ensure the proposals are fully and fairly assessed, the Developmental Research Program uses a rotating panel
of highly qualified external reviewers with their own cancer-related NIH funding. The JHU Sidney Kimmel
Comprehensive Cancer Center will provide $75,000 annually as match funds for the Developmental Research
Program, while UAB will contribute $50,000 annually to be used in the Developmental Research Program with
option to modify as needed. In addition, the Johns Hopkins University School of Medicine will provide a single
year of $75,000 Discovery Award funding to further leverage NIH support to encourage innovation within our
program.